High content screening system - Perkin Elmer Opera Phenix Plus

This is a Shared Instrument Grant proposal for the acquisition of a high content imaging system, the Perkin
Elmer Opera Phenix Plus to replace three discontinued IN Cell high content systems which will no longer be
supported as of 2025. The current three IN Cell instruments reside in three important Core facilities at the
Mission Bay Campus of the University of California, San Francisco (UCSF). High content imaging is a key
service for many investigators at UCSF who use the core services of the Small Molecule Discovery Center
(SMDC), the Center of Cellular Construction CCC) and the Environmental Research and Translation for Health
(EaRTH). Many of our investigators have research projects that screen for morphological changes in a high-
throughput manner for varying conditions (e.g. pH, gene knockouts, environmental chemicals, small molecule
drugs) in a wide variety of biological samples (e.g. mammalian tissues and organoids, Stentor, budding yeast,
nematodes, zebrafish, neurons and phase separation droplets) using high content image-based screening.
The Opera Phenix Plus system can act as a replacement for all three IN Cell instruments due to its
simultaneous 4-camera system that reduces the acquisition time such that it is at least four times faster than
the top of the line IN Cell 6000 and 6500 that reside currently in our Cores. With the faster throughput, the new
instrument will be able to accommodate all the users from the three different Cores. In addition, the faster
acquisition will allow 3D time-lapse imaging that many of our investigators attempted on our IN Cells but were
not satisfied with time it took to complete a 96-well plate, typically over an hour for a typical sample compared
to twelve minutes with the Opera Phenix Plus. The new instrument also is equipped with water immersion
lenses for 20, 40 and 63x magnification, which due to better refractive index matching, gives higher resolution
images than could be obtained in the IN Cell instruments which relied on air objectives. The Opera Phenix Plus
is also equipped with lasers for multi-wavelength imaging, environmental control, automation and easy-to-use
imaging processing software that are needed for our investigators to successfully conduct their research. The
innovative research programs of our users span a wide range of basic, translational, and clinical research
areas as well as address many health-related areas in the realms of cancer, developmental, reproductive and
neurological disorders. All 17 Major and Minor users have NIH grants that support their high content imaging.
The Opera Phenix Plus will be essential to continue and further develop our biomedical research for many
years to come.

Public health relevance
This is a Shared Instrumentation Grant proposal requesting funds to purchase a state-of-the-art Opera Phenix Plus High Content Screening System. The requested instrument would act as a single replacement for three IN Cell high content laser confocal systems serving three Cores that have been discontinued by their company with no parts or service available at the end of 2024. The new instrument will allow multidisciplinary teams of investigators at the Mission Bay Campus of the University of California to continue to conduct a wide range of cutting-edge experiments spanning developmental biology, cellular engineering, and neurophysiology, cancer biology and organoid development.